Prospective Study Of Anti-hepatitis C Virus Positive B

This protocol is designed to study the natural history and epidemiology of hepatitis C virus (HCV) infection in an asymptomatic blood donor population. Thus far, 720 subjects have been enrolled, including 422 recombinant immunoblot assay (RIBA) positives, 186 RIBA indeterminates, and 112 RIBA-negative controls. The early data have been published and the trends have remained the same over time. Unexpected findings were the high proportion (41 percent) of RIBA+ donors who admitted to prior (remote) intravenous drug use and the strong independent association between cocaine snorting and HCV positivity. Shared paraphernalia for snorting accompanied by epistaxis, may serve as a covert vehicle for parenteral viral transmission. Among anti-HCV+/RIBA-positive donors, 87 percent were persistently viremic, but 13 percent appeared to have recovered from prior HCV infection. A liver biopsy has been obtained from 135 patients who were chronically infected; 51% had mild chronic hepatitis and 44% had moderate chronic hepatitis; despite a mean duration of infection of 20 years,only 5% had severe inflammation,10% significant fibrosis and 1.5% cirrhosis. Overall, HCV infection in this cohort was generally asymptomatic and clinically benign. Despite an association of HCV with sexually promiscuous practices, we found no evidence for sexual transmission to the specific partners of 116 HCV-infected individuals. The study continues to follow the natural history HCV infection and is now focusing on histologic progression as assessed in liver biopsies obtained at 5-year intervals. New emphasis is being placed on studies of cell-mediated immune responses to HCV and of treatment responses. The 10 year experience with this cohort is being analyzed for publication.